Development and Validation of a Robust and Modular Host: Guest-based Pretargeting Platform

Project Summary
Molecular imaging approaches that utilize monoclonal antibodies (mAbs) have shown great promise, but their
extension into clinical practice is often difficult due to high radiation doses and inconvenient image acquisition
intervals. These problems stem from the long-lived radioisotopes that are necessary to match the physiological
properties of the mAbs themselves, namely a long in vivo half-life. Several pretargeting platforms, which aim to
eliminate the dosimetry concerns by decoupling the radioisotope from the mAb, have been utilized successfully
in preclinical models and with limited success in a clinical setting. However, to be widely applicable and
translatable, pretargeting systems need to be robust, modular, and compatible for human use, and all of the
platforms reported to date have not met those requirements. Broadly, the limitations of the predominant
pretargeting platforms reported to date are non-modularity of the pretargeting components, intrinsic instability
of the reactive ligands, or immunogenicity. Thus, we believe that taking advantage of the immense potential of
pretargeting necessitates the development of a platform that is based on robust ligands that are amenable to a
modular approach and are compatible with human use. We propose to develop a platform that meets these
rigorous demands by utilizing the “host:guest” pair curcubit[7]uril (CB7) and adamantane (Adma). CB7 is known
to rapidly form a strong, noncovalent interaction with Adma ligands, exhibiting similar kinetic and stability
properties as biotin and streptavidin. We believe that this host:guest pair is ideal for development of a
pretargeting platform for several reasons. First, CB7 may be easily functionalized for attachment to mAbs while
Adma can be easily functionalized for radiolabeling with essentially any PET radioisotope, providing the requisite
modularity. Additionally, neither functionality susceptible to racemization or prone to degradation, suggesting
they are suitably robust. Finally, both CB7- and Adma-containing molecules have been reported as suitable for
human use in various forms. Given the exceptional host:guest chemistry between CB7 and Adma-based
compounds as well as their satisfaction of the above criteria for successful pretargeting platforms, we propose
to develop and evaluate a pretargeted PET platform based on these compounds. The goal of the proposed
project is to develop CB7-conjugated mAbs as well as Adma-containing ligands labeled with PET emitting
radioisotopes. We will carry out a rigorous optimization of the pretargeting components and test our lead
candidates using in vivo murine models of cancer. If successful, our pretargeting system could be the first to
fully seize upon this concept of pretargeted PET imaging in a way that is widely applicable for human use. In
doing so, we could alter the course of antibody-based PET imaging for precision medicine.

Public health relevance
Project Narrative The need for antibody-based PET imaging probes for precision medicine applications is becoming more urgent, but their clinical use has been hampered by high radiation doses to patients and inconvenient image acquisition intervals related to the use of long-lived radioisotopes. Pretargeting is a strategy that decouples the radioisotopes from their antibody targeting vectors to overcome these problems, but current strategies have suffered from immunogenicity, instability of the components, or nonmodular design. We propose the development of a modular host-guest based pretargeting platform that is designed around stable, non-immunogenic components, which we believe will carry pretargeting to the forefront of antibody-based precision medicine.